Disentangling Tissue and Ome Shared and Private Effects of Exercise

Project Summary/Abstract
Exercise is a powerful intervention against many chronic diseases but the molecular
mechanisms of this protection remain unclear. We propose an innovative, integrative approach
to analyze the complex effects of exercise on multiple biological levels using the extensive data
collected by the Molecular Transducers of Physical Activity Consortium (MoTrPAC). This
dataset includes multiomic, multi-tissue, and multi-time point profiling after endurance exercise
training in both rats and humans, offering an unprecedented opportunity to explore the
mechanisms underlying the health benefits of exercise. Existing studies analyze individual omes
and tissues separately, which risks missing subtle shared signals and conflating differences in
statistical power with true biological variation. To overcome these limitations, we propose an
integrative analysis based on our recently published Multiset Correlation and Factor Analysis
(MCFA).
Our first aim is to extend MCFA to handle tensor-valued data, creating a new model we call
tensor-MCFA (tMCFA). This model will explicitly account for multimodal, multi-tissue data by
dividing variation into four categories: (tissue, ome)-tuple private, tissue-private, ome-private,
and shared. We will design tMCFA to handle and impute missing data pairs and explore linking
related features across omes using a graph-guidance strategy.
In our second aim, we will apply tMCFA to the Preclinical Animal Study Site (PASS) dataset
from MoTrPAC. We will incorporate alternative splicing as an additional modality for analysis
and assess the proportion of variance explained by each of the four categories. To interpret
these components, we will use gene set enrichment analysis and protein-protein interaction
enrichment. By relating our findings to human expression data and various metabolic diseases,
we aim to identify how exercise-related changes observed in rats correspond to protective
effects against human diseases. This comprehensive analysis across tissues and omes will
allow us to pinpoint the key drivers of exercise's protective effects.
Through this work, we hope to provide novel insights into the molecular mechanisms underlying
the health benefits of physical activity. Our findings could pave the way for new therapeutic
strategies and personalized exercise interventions that maximize these protective effects.

Public health relevance
Project Narrative We aim to uncover how exercise protects against diseases like cancer and Alzheimer’s by analyzing complex biological data from the Molecular Transducers of Physical Activity Consortium (MoTrPAC). Using advanced computational methods, we will integrate data across different tissues and molecular layers to identify shared and unique biological changes caused by endurance exercise. This research could reveal key drivers of exercise’s health benefits, offering insights into disease prevention and personalized fitness strategies.